Characterization of Francisella tularensis-specific bacteriophages

Bacteriophages are viruses that infect and kill bacteria either by disrupting their metabolism or by causing
bacterial lysis. These unique properties of bacteriophages have been exploited as antimicrobial agents for over
100 years. The emergence of antibiotic resistance and the lack of introduction of new antibiotics in recent years,
has renewed interest in the development of bacteriophage-based therapies in clinical situations where antibiotics
are no longer effective. The overall goal of this proposal is to characterize a panel of bacteriophages that could
further be developed as a therapy to treat fatal human disease tularemia caused by a Gram-negative bacterium,
Francisella tularensis (Ft). Ft is a highly ubiquitous, infectious, intracellular bacterium prevalent throughout North
America. Ft is classified as a Tier 1 Category A select agent by the CDC due to its history of weaponization by
several countries, and its potential to be used as a bioterror agent. Anthrax powder attacks after 9/11 incidence
have renewed the medical and scientific interest in Ft research. Tularemia is a notifiable disease in the USA.
Naturally occurring tularemia is reported from all the states of the USA, except Hawaii. Currently, no vaccine is
available for tularemia prophylaxis. Unfortunately, antibiotic treatment is not particularly effective against severe
respiratory tularemia and may not be effective at all, if a weaponized antibiotic-resistant strain used in a bioterror
attack causes an outbreak. Together, these indicate that the development of effective therapeutic measures
against this dreaded biothreat agent is necessary. Bacteriophages may provide an excellent alternative to the
conventional antibiotic therapy for the treatment of tularemia with the added advantage being that they are
innocuous, self-replicating, amplify at the site of infection, and do not perturb microbiota. However,
bacteriophages against Francisella have not been reported in the literature to-date. As a proof-of-concept, we
have isolated a panel of Francisella-specific lytic phage populations from environmental samples. In specific aim
1 of this proposal, we will isolate a collection of individual Ft-specific phages from these samples and characterize
their genetic, biochemical, and physical properties. In specific aim 2, we will characterize their biological
properties. Specifically, we will determine their growth characteristics, host-range, and potential cell surface
receptors. We will formulate an Ft-specific phage cocktail and develop assays to test the ability of phage
cocktail(s) to kill intracellular Francisella. This is a first comprehensive study directed at the characterization of
Ft-specific bacteriophages. Isolation and characterization of Ft-specific phages against Category A Tier-1 select
agent Ft SchuS4 and formulation of novel Ft-specific bacteriophage cocktail capable of killing intracellular
bacteria constitute the most innovative aspects of this proposal. We expect that the outcome of the proposed
studies will pave the way for the development of a novel therapeutic approach for the treatment of tularemia in
humans.

Public health relevance
Project Narrative Francisella tularensis (Ft) is the causative agent of a fatal human disease known as tularemia. Ft is classified as a Category A select agent by the CDC due to its extremely high virulence and its potential as a bioterrorism agent. This proposal focuses on the characterization of novel bacteriophages against Ft that can further be used as a therapy for the treatment of respiratory tularemia. The outcome of the proposed studies will provide an excellent substitute for conventional antibiotic therapy for the treatment of tularemia caused by naturally occurring or weaponized antibiotic-resistant strains of Ft.